ITCA NARCH 12 Capacity Building Core

NARCH XII Capacity Building Project: Building our Tribes’ Capacity to Initiate Community-Based
Research Abstract
Building on the expertise of the Arizona Tribal Research Review Board being developed by the Inter Tribal
Council of Arizona (ITCA) through NARCH XI, this project will provide funding and extensive mentorship to
Arizona Tribes to initiate research projects in their own communities. During the project period, ITCA will fund
up to ten Arizona Tribes to develop, implement, and evaluate their own community-based research projects.
ITCA funding of the community projects will be through a competitive process that is based on evidence of the
project’s feasibility and the community’s resources to accomplish their research objectives. The funded Tribes
will receive technical assistance and mentoring from a team of American Indian researchers at the University
of Arizona with research expertise and a track record of writing and implementing successful research studies
with Tribal communities. The UA research team will provide supplemental assistance to up to two projects that
show readiness for submission to a national funding agency.

Public health relevance
NARCH XII Capacity Building Project: Building Our Tribes’ Capacity to Initiate Community-Based Research Project Narrative Tribal research sovereignty will not be realized until Tribes are self-empowered to fully manage the research process ranging from problem identification to implementation, analysis, and dissemination. Tribally-initiated projects are more likely to address the structural causes of disparities and Tribal solutions are more likely to be sustained within the community. The ITCA Capacity Building project aims to provide Tribe-specific and culturally-relevant mentorship to support Tribal projects as they are conceived within the Tribal community through mentorship and technical assistance of the American Indian Research Center for Health (AIRCH) and collaborative partners with expertise in Tribal research.